EFFECTS OF WHEY PROTEIN ON WEIGHT LOSS AND METABOLIC STATUS OF MIDLIFE ADULTS: A

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to test the feasibility of whey protein to promote energy balance in midlife women (40-60 years old) in a clinical study.